Detroit Research on Cancer Survivors (Detroit ROCS)

Project Summary/Abstract
Despite progress made in early detection and treatment, African Americans continue to experience
disproportionately higher cancer incidence rates, are first diagnosed with more advanced stage disease,
and suffer higher mortality rates than other populations. The Detroit Research on Cancer Survivors
(ROCS) study (U01CA199240) is the largest single cohort of African American cancer survivors aimed
at understanding the multiplex causes of poorer outcomes in this population. Detroit ROCS has been
collecting survey data and biospecimens with a goal of enrolling 5,000 population-based African
Americans diagnosed with lung, breast, prostate, colorectal, and endometrial cancers and any early-
onset cancer (diagnosed age 20-49 years) and supporting studies addressing determinants of cancer
outcomes and quality of life. In this renewal application, we will continue to follow cohort survivors
annually for up to 9 years to address the determinants of longer term outcomes (e.g., disease
recurrence, second primary diagnoses, treatment related comorbidities and death) and quality of life.
The broad research agenda will be developed with our community partners. We propose to: 1) conduct
annual follow-up surveys on all living, enrolled participants for up to five additional years and collect
additional biospecimens; 2) engage with members of the community to set new research priorities and
to obtain input into the retention of participants and dissemination of research findings back to the
community; 3) link Detroit ROCS patient data to other existing sources of health-related and exposure
data to supplement patient-reported information; and 4) extend collaborations to facilitate use of the
data and biospecimens by the broader research community. Detroit ROCS is providing substantial data
and biospecimens to facilitate studies aimed at understanding and addressing determinants of poor
outcomes in this population.

Public health relevance
Project Narrative/Relevance African Americans continue to have poor outcomes after a cancer diagnosis and few African American cohorts exist to support studies of the determinants of cancer prognosis and progression, survival, quality of life and post-treatment outcomes. The proposed continuation of follow-up of this cohort of population-based, African American cancer survivors will provide longer-term outcomes data and biospecimens for a research agenda driven by priorities in the African American community and aimed at understanding and improving cancer outcomes in this population.